Individual functional brain mapping for biomarker discovery in Alzheimer's

PROJECT SUMMARY: Alzheimer’s disease (AD) affects over 6 million Americans, and its incidence is projected
to double by 2050 due to an aging population. In the fight against AD, there is a pressing need for novel
biomarkers to 1) identify clinical trial participants at risk of decline and 2) identify and track patients eligible for
emerging treatments. Gold standard AD biomarkers require positron emission tomography (PET) imaging or
cerebral spinal fluid (CSF) collected via lumbar puncture. These procedures are expensive and/or invasive,
presenting a barrier to widespread adoption. Blood-based biomarkers are under development but are not yet
validated and may benefit from combination with other biomarkers. A principal goal of the Alzheimer’s Disease
Neuroimaging Initiative (ADNI) 3 is to promote development of novel AD biomarkers, including the use of
functional magnetic resonance imaging (fMRI). FMRI is used to study the functional connectivity (FC) and
organization of the brain, and fMRI studies have revealed functional brain changes associated with AD. FMRI-
based biomarkers of AD could complement existing biomarkers by providing a non-invasive, first-line screening
method before PET and CSF are collected. FMRI could also be combined with blood biomarkers and established
structural MRI markers—all of which can be routinely collected clinically—to construct powerful and widely
available multimodal biomarkers. Despite all of this, no fMRI-based biomarker for AD exists to date. This is in
part due to the high noise levels of fMRI and the common use of naive statistical methods, which together lead
to noisy estimates of FC and other functional brain features. Two conventional workarounds—averaging many
subjects or collecting hours of data on individual subjects—are not viable clinically. This project will address this
gap by developing computationally efficient Bayesian techniques with high accuracy and deploying those
methods for fMRI-based biomarker discovery in AD. Our models leverage information across subjects via
population-derived priors or “templates”, which are previously estimated, to extract nuanced and precise
functional brain features in individuals. These models avoid the need for burdensome prolonged scans. They
can be fit to data from a single subject at a time, making them clinically viable and computationally advantageous.
To maximize the benefits of hierarchical modeling, we utilize grayordinates data, a recent technological advance
in image processing that improves inter-subject anatomical alignment. To deploy these techniques effectively in
multi-site datasets like the ADNI, image harmonization is necessary to avoid confounding site effects. Existing
harmonization methods can be applied to fMRI summary measures, but are not applicable to fMRI time series,
which are a complex mixture of latent features. To address this critical gap, we will develop a novel harmonization
method for fMRI time series data, with high potential impact on fMRI processing pipelines. Finally, we will analyze
fMRI data from ADNI to extract functional brain features and build novel fMRI-based AD biomarkers. While our
focus is AD, this project will have broad implications for fMRI-based research and care.

Public health relevance
PROJECT NARRATIVE: In the fight against Alzheimer’s disease, functional magnetic resonance imaging (fMRI) holds promise as a non-invasive, widely available, relatively inexpensive source of biomarkers that could help advance clinical trials and clinical care. A barrier to fMRI-based biomarkers is the challenge of individual precision, given the high noise levels of fMRI data. This project will produce novel statistical techniques for fMRI analysis capable of extracting accurate, nuanced functional brain features in individuals and will deploy those techniques to develop fMRI-based biomarkers of Alzheimer’s disease.